Improved Treatment of Distal Radius Fractures Using an Image-Guided, Percutaneous Delivery of a Novel Bone Adhesive

Project Abstract/Summary
Falls from standing height and other low-energy trauma account for 87% of all orthopedic fractures among the
elderly. Distal radius fractures (DRF) are one of the most common types of these fractures, with approximately
40% of the more than 675,000 DRF cases reported annually in the U.S. occurring in people aged 65 years or
older. Unfortunately, these injuries result in difficulty performing the most basic daily tasks and, for elderly
patients, can lead to a loss of independence, a reduction in quality of life, and even increased mortality.
The current standard of care for DRF injuries is open reduction internal fixation (ORIF) procedures that involve
placement of metal hardware such as volar plates and/or K-wires. Results of these open surgical approaches
have been mixed; complication rates have been reported to be as high as 36% in the elderly and involve the
onset of carpal tunnel syndrome, complex regional pain syndrome, and have led to tendon irritation and rupture,
deep infections, and the need to re-operate to remove the plates.
To address this issue LaunchPad Medical (LPM) has developed Tetranite® (TN), a novel bone adhesive
biomaterial that can bond bone fragments together, fill bone voids, and adhere bone to metal. Over time this
innovative material acts as a scaffold, promoting healing and allowing bone to grow through it to ultimately
replace it with new, vital bone. TN’s robust bond strength, when subjected to shear loading to the various
substrates, has been shown to be significantly greater than non-adhesive bone cements on the market. Yet
when properly mixed, TN’s flow properties make it ideal for percutaneous delivery. Uniquely, TN can be loaded
with BaSO4 without significant degradation to its mechanical properties, making it possible for a surgeon to
monitor its placement in vivo via fluoroscopy in real time and without the need for open surgery.
In Phase I of this project the TN adhesive chemistry was characterized and optimized to yield a product with
sufficient mechanical and microstructural properties to fixate upper extremity bone fractures on a stand-alone
basis (without the use of metal fixation hardware). Preliminary cadaver studies have demonstrated the effective
percutaneous treatment using the optimized formulation. Building on this successful Phase I project, and other
preliminary R & D, TN’s translation to a clinical indication for treating DRF injuries will continue in the proposed
Phase II study through the completion of the following: Aim 1: Optimization of the Percutaneous Delivery of
TN for DRF Procedures and Aim 2: Demonstration of the Safe and Effective Use of TN in a Large Animal
Study.
The results from this translational animal study, complemented with surgeon validated simulated use cadaver
testing, will be used to as the basis for filing an Investigational Device Exemption (IDE) with the FDA to initiate
human studies. Long term, LPM’s mission is to provide surgeons with a novel product that will enhance fixation,
reduce complications and revision surgeries associated with DRF procedures in the elderly.

Public health relevance
Project Narrative Distal radius fractures (DRF) are one of the most common types of these fractures in the elderly, with approximately 40% of the more than 675,000 DRF cases reported annually in the U.S. occurring in people aged 65 years or older. These injuries often result in difficulty performing the most basic daily tasks, a reduction in quality of life, and even increased mortality. Results from the current standard of care for DRF—open surgery employing internal metal fixation— have been mixed; complication rates have been reported to be as high as 36% and involve the onset of carpal tunnel syndrome, complex regional pain syndrome, tendon irritation and rupture, deep infections, and the need to re-operate to remove the plates. This project will demonstrate that Tetranite®— a novel bone adhesive that can be administered percutaneously using image-guidance in real time during surgery—can be used by itself to fixate metaphyseal bone in a large animal model; this will be an important next step in the development of a bone adhesive option for treatment of DRF injuries.